Development of Blood Delivery Networks for Silicon Nanomembrane-Enabled Low-Volume Membrane Oxygenators

Abstract
The overall goal of this project is to optimize performance and hemocompatibility of prototype blood
oxygenators enabled by silicon nanomembranes. To achieve this, the project brings together expertise
in blood-contacting medical device hemodynamics (Co-PI Steven Day; Chair and Prof. Biomedical Engi-
neering, Rochester Institute of Technology) with silicon nanomembrane production at SiMPore Inc.
(Co-PI James Roussie). Together, SiMPore and RIT offer a high impact and innovative approach for pro-
ducing device geometries and material systems. SiMPore’s nanomembranes offer orders-of-magnitude
higher permeability than polymer membranes used in current ECMO oxygenators and compelling pre-
liminary data are demonstrative of these advantages. Since the overall volume of an oxygenator is de-
pendent on the surface area and permeability of its membranes, incorporating SiMPore’s highly perme-
able silicon nanomembranes into an efficient blood delivery and gas exchange system will lead to
scaled down circuit blood volumes and dramatically lower surface areas of blood exposure. Leveraging
Co-PI Day’s expertise in modeling and testing of hemolytic and thrombogenic potential of blood-con-
tacting medical devices, a blood delivery network will be iteratively designed in silico and tested with
installed nanomembranes in vitro so that the full permeability of nanomembrane-based oxygenation is
realized within a safe and efficient device geometry. Aim 1 will focus on iterative in silico prototype oxy-
genator design and initial empirical performance characterization, while Aim 2 will focus on a perfected
design’s hemocompatibility and comparative performance versus currently in-use polypropylene mem-
brane oxygenators. Success out of this R21 project will lay the basis for testing of the nanomembrane-
based oxygenator in animal models.

Public health relevance
Narrative A significant problem when treating life-threatening lung problems in newborns and infants is the large size of lung function replacement devices (known as extracorporeal membrane oxygenators). This project aims to miniaturize the size of such devices to a scale more appropriate for newborns, accomplished through the use of highly permeable silicon nanomembranes that will replace the less permeable polymer membranes typically used in currently approved devices. This project focuses on designing and testing the blood delivery method so that gas exchange may occur more efficiently, thereby reducing problems associated with the larger blood volumes of current devices, namely, bleeding- and clotting-related risks.